Unraveling the Mechanisms of Protein Sorting and Localization to Organelles

PROJECT SUMMARY
Protein import to subcellular compartments is fundamental to maintaining cellular and organelle proteostasis.
The sorting of nascent proteins begins during their synthesis on ribosomes and is mediated by molecular “zip
codes” encoded within their primary sequence. In the subsequent steps, a network of chaperones and receptors
mediate protein processing and folding during import on the respective organelle membrane. Disruptions in these
pathways can lead to protein misfolding and aggregation, contributing to the onset of neurodegenerative
diseases such as Alzheimer’s and Parkinson’s. Furthermore, defects in protein import are linked to Congenital
Disorders of Glycosylation (CDG), highlighting the critical health implications of our research focus.
My lab aims to uncover the molecular mechanisms for protein biogenesis on mitochondrial and endoplasmic
reticulum (ER) membranes. The two ambitious projects in my research program will explore: 1) how nascent
polypeptide chains are processed and folded by chaperones during transport across the ER membrane, and 2)
the molecular basis of mitochondrial protein import. Here, we will employ a set of innovative and integrative
approaches such as cell-free protein synthesis and cell-based assays to trap ribosome-nascent chain complexes
at different stages during protein import. We will then employ high-resolution cryo-electron microscopy and
cellular cryo-electron tomography to determine the structures of these ribosome complexes with associated
chaperones and receptors on the ER and mitochondrial membranes to delineate their molecular interactions at
atomic detail. Finally, we will conduct functional studies, both in-vitro and using cell-based assays, to complement
and validate our structural observations.
Our research program is uniquely positioned to fill critical gaps in the understanding of co-translational protein
sorting and processing on organelle membranes. The anticipated outcomes will provide molecular snapshots of
these processes with novel insights and implications for therapeutic strategies targeting protein misfolding and
aggregation in disease.

Public health relevance
PROJECT NARRATIVE The essential process of protein localization to organelles is fundamental for maintaining cell proteostasis. This proposal employs integrative approaches in biology to uncover the intricacies of ER and mitochondrial protein biogenesis. The anticipated research outcomes hold significant implications for health, particularly in understanding the onset of neurodegenerative diseases.